Sex Specific Regulation of B1 B Cell Self-Renewal and Natural Antibody Production

PROJECT SUMMARY/ABSTRACT
Lower respiratory tract infections such as pneumonia claims the lives of approximately 4 million people worldwide
each year, making these infections fourth on the list of global causes of death. Streptococcus pneumoniae is the
most common cause of pneumonia leading to death in individuals over the age of 65 eight times more frequently
than those aged 5-49, despite the long-standing availability of a vaccine for this age group (approved in 1983).
In both murine and human systems, there is a greater incidence of, and susceptibility to, pneumococcal infection
in males; nevertheless, the factors contributing to this difference between males and females are unknown.
Therefore, the long-term goal of this study is to gain a greater understanding of the immune system in the context
of sex. Specifically, the goal of this proposal is to determine whether sex and/or anatomical location influences
a specific subset of B cells, B1 cells, which provide essential protection and therefore survival from S.
pneumoniae infection through production of natural antibodies.
Antibodies provide defense against infection by binding the pathogen and preventing infection of host cells.
Natural antibodies are present in the absence of infection or intentional immunization. B1 cells’ unique ability to
provide protection against S. pneumoniae is attributed to their production of natural antibodies, which have
unique structural characteristics resulting from their fetal development. Fetal derived B1 cells maintain their
population through a self-renewal process, which is unlike the B cell subset, B2 cells, generated from
hematopoietic stem cells. Therefore, self-renewal is essential for the maintenance of natural antibodies
protective against infection, though little is known about how sex influences self-renewal of B1 cells into old age.
We have demonstrated natural antibody from aged male mice does not provide protection against S.
pneumoniae infection whereas, natural antibody from aged females maintains its protective capacity.
We hypothesize that maintenance of B1 cells through self-renewal is influenced by sex during aging. We
postulate that female B1 cells maintain more productive B1 self-renewal allowing for the differences seen in
susceptibility to infection with sex and age. To test this hypothesis, we will perform the following aims: 1) elucidate
the sex-specific developmental differences regulating B1 cells by examining cell cycle maintenance through a
unique transgenic reporter line combined with examination of self-renewal to determine the functional
consequence of sex, age, and cell cycle activity on the production of protective antibody and 2) determine how
maintenance of self-renewal in humans may mirror the murine system and influence production of natural
antibody. This project will determine how sex influences the maintenance of B1 cell self-renewal and the
subsequent impact on the production of natural antibodies during aging. This further understanding of the
immune system in context to sex will likely suggest new prevention and/or treatment strategies of S. pneumoniae
infection in both male and female aging populations.

Public health relevance
PROJECT NARRATIVE B1 lymphocytes mediate the immune response to infection, providing immediate and essential protection against Streptococcus pneumoniae, which in both human and murine systems infection disproportionally effects the aging population, claiming the lives of people over 65 eight times more frequently than others. B1 cells maintain themselves through a unique self-renewal process and provide pneumococcal protection through production of natural antibody; however, our results demonstrate natural antibody obtained from aged males does not provide protection against S. pneumoniae while natural antibody from aged females does maintain protective capacity. This project will determine the role sex plays in the ability of B1 cells to maintain self-renewal into old age and subsequently produce protective natural antibodies.